U-RISE at Texas State University

Project Summary/Abstract
Texas State University (TxState) will implement an Undergraduate Research Training Initiative for Student
Enhancement program (U-RISE Tx) to increase the diversity and number of TxState students entering PhD
programs in biomedical research. We will recruit qualified Hispanic and other underrepresented (UR) students
for extensive undergraduate research experiences in chemistry, biochemistry, and biology and provide these
students with the skills, mentoring, training, and support necessary to excel in graduate school and beyond. U-
RISE Tx will synergize with other successful NSF- and NIH-funded programs at TxState to broadly improve the
training environment through evidence-based training and mentoring methods that will be implemented across
multiple departments. This program will accomplish its goals through the following Specific Aims:
Recruitment: We will employ a robust recruitment strategy that includes Browse Sessions during University
open-house recruitment events for prospective high school seniors (Bobcat Days) and during New Student
Orientation events; STEM-focused sections of the mandatory first-year seminar course US1100 and additional
campus-wide advertising targeting STEM freshmen. Pre-RISE: Bi-weekly seminars for freshmen will provide
information regarding strategies for academic success, career decision making, and careers in the biomedical
sciences. These sessions will include preparation for summer REU programs at one of our partner Tier-1
research institutions and will foster a community to build student self-confidence, social and cultural capital,
and scientific identity. Mentored research: First-year student applicants will be selected to join the U-RISE Tx
program at the end of the Spring semester. U-RISE Tx trainees will participate in required coursework,
structured activities, and independent research projects with program faculty mentors. Throughout the
program, trainees will participate in training for responsible conduct of research, research rigor and
reproducibility, ethics, and laboratory safety. Trainees will participate in at least one summer REU program at
one of our two partner T32-hosting research universities. An innovative aspect of the U-RISE Tx program is its
integration of laboratory automation training, with associated improvements in efficiency and reproducibility,
and training in proper protocols for record-keeping in both traditional and electronic lab notebooks.
Professional development: Faculty research mentors will participate in both local and national workshops
and seminars for mentorship. Trainees will participate in extensive career development activities focused on
transitioning to PhD programs using Individual Development Plans and Research Portfolios. Teamwork, social
interactions, and peer mentoring will develop a strong sense of belonging and science identity of trainees, who
will also have multiple opportunities to present their research within the program and at local and national
meetings. Trainees and their mentors will undergo continual formative evaluation to ensure the quality of the
program aided by an Oversight Committee and an External Advisory Committee.

Public health relevance
Project Narrative The biomedical research community must include individuals from diverse backgrounds in order to foster scientific innovation and to increase the likelihood that the discipline will address issues of health disparities and the needs of underserved populations. The U-RISE Tx program will increase the number of Hispanic and other underrepresented undergraduate students who enroll in biomedical PhD programs and pursue research- related careers.